Development and availability of the Collaborative Cross (CC) panel of recombinan

The Collaborative Cross (CC) is a panel of recombinant inbred lines derived from eight founder mouse strains. We have recently genotyped 450 CC lines to provide the first accurate description of the genetic architecture of the CC population. We are now focused on making the largest number of lines accessible to the researchers as soon as possible through genotyping and re-derivation of CC lines nearing the thresholds for distribution (>90% inbred) and completion (>98% inbred). There are currently 27 CC lines in the distribution list and we expect to have a minimum of 50 CC lines by the end of 2012 and 100 CC lines by 2103. The CC is a Genetic Reference Population and, therefore, the number of lines available has a direct impact in the power of detecting loci with small to moderate effects and on the ability to select lines that are uniquely suited to specific research projects.